Mechanisms governing development of large-scale networks in visual cortex

Abstract
Sensory perception requires the coordinated activity of tens of thousands of neurons, working together in large-
scale functional networks. Developmental events define and constrain the ultimate capabilities of these networks,
therefore it is essential to understand the mechanisms underlying their formation. In the visual cortex of primates
and carnivores, columnar networks of orientation preference extend across millimeters of cortical surface. Prior
to eye-opening, such large-scale networks are already evident in correlated spontaneous activity, whose
structure can predict future visually-evoked responses. However, a major gap in our ability to relate early network
structure to mature sensory function is the lack of knowledge of the circuit mechanisms through which millimeter-
scale correlated activity is generated in the early cortex. The experiments in this proposal will address this gap
and test the hypothesis that large-scale correlated networks in the early cortex are generated by propagating
activity through purely short-range intracortical connections and are refined through the emergence and
elaboration of monosynaptic horizontal projections. By employing wide-field calcium imaging in early visual
cortex, the experiments in this proposal will directly assess propagation in early spontaneous activity. A key
prediction of our hypothesis is the interdependence of cortical domains in generating correlated activity. We will
test this by determining whether local pharmacological or optogenetic silencing of cortical activity leads to a
global disruption of correlated network activity. In order to identify the contribution of inhibitory neurons to the
structure of correlated networks in the early cortex, we will utilize inhibitory-neuron specific labelling and 2-photon
calcium imaging, together with targeted optogenetic manipulations. Finally, as these early correlated networks
undergo refinement during the same period that long-range horizontal projections begin to elaborate in layer 2/3,
we will combine anatomical labeling with longitudinal functional imaging of spontaneous activity. This will allow
us to determine whether emerging horizontal connections link domains that are already functionally correlated,
or instead act to reshape functional networks in the early visual cortex. Together, these studies will provide
critical new insights into the circuit mechanisms governing the formation and refinement of large-scale correlated
networks in the early cortex. In doing so, they will provide a key framework for understanding how the patterns
of early cortical activity establish the organization of developing cortical networks and impact later sensory
perception.

Public health relevance
Project Narrative This proposal will identify the circuit mechanisms responsible for generating large-scale networks in the early cortex, providing insights central to understanding how alterations in early network formation impact later sensory perception. In addition, these insights will be relevant for addressing the numerous neurodevelopmental disorders with abnormal sensory processing, such as autism and schizophrenia, as well as the broader range of neurological and psychiatric disorders involving abnormal functioning of cortical networks.